IGF::OT::IGF Task Order 4 for Clinical Support for a phase 1 clinical interaction study between lorcaserin and cocaine POP: 08/18/2014 -08/17/2015.

The purpose of this contract is to provide pharmacokinetic resources in support of PK/PD studies. No actual clinical or laboratory studies will be carried out under this contract. The types of studies the contract will support include clinical pharmacology/pharmacokinetic studies and interaction studies between study medications and specified drugs of abuse.